Core 2: Biostatistics and Bioinformatics Core

Core 2. Biostatistics and Bioinformatics
Abstract
The Biostatistics and Bioinformatics Core of the MSCP SPORE provides services for the design of experiments
and the analysis of in vitro, in vivo, clinical, translational and -omics data. The investigators and staff of both
segments of the Core have significant experience in research in skin cancers, so that data are analyzed in the
appropriate scientific context, increasing the Core's efficiency and effectiveness compared to general purpose
data analysis services. The Biostatistics and Bioinformatics Core combines classical statistical techniques with
contemporary Bayesian, machine learning and genomics methods to ensure that every research project, DRP
and CEP awardee in the MSCP SPORE has access to the most appropriate analyses. The Core will also work
closely with Core 1 to ensure that data flows between laboratories, clinics and analysts are efficient and that
data and resource sharing can be effective and comprehensive.

Public health relevance
Core 2. Biostatistics and Bioinformatics Narrative The Biostatistics and Bioinformatics Core provides specialized analysis services to the clinical, laboratory, translational and -omics research projects of the MSCP SPORE to ensure that experiments are efficiently designed, and data are analyzed in a rigorous and reproducible fashion by analysts familiar with cancer in general and melanoma and other skin cancers in specific.